HIV Database and Analysis Unit

This agreement is for the operation of a computerized HIV database and analysis unit that provides an international research resource to aid in the development of vaccines and therapies and in the understanding of the pathology, genetics, and evolution of HIV.

Public health relevance
This agreement is for the operation of a computerized HIV database and analysis unit that provides an international research resource to aid in the development of vaccines and therapies and in the understanding of the pathology, genetics, and evolution of HIV.